The Role of TGFβ2 and Macrophages in Cancer Cachexia

SUMMARY
Cachexia is a significant contributor to increased mortality in various chronic diseases, including cancer. Patients
with cancer cachexia experience unintentional body weight loss, which can involve muscle loss, with or without
fat mass. The decline in muscle mass not only impairs muscle function, but also diminishes quality of life and
raises mortality risk. Our preliminary research has revealed an upregulation of transforming growth factor 2
(TGFβ2) preceding the recruitment of M2 macrophages to the skeletal muscle in cachectic mice. Additionally,
we observed that depleting M2 macrophages inhibited the transition from cachexia to severe cachexia by
preserving muscle mass and reducing fibrosis. These data highlight the involvement of M2 macrophage
activation in cachexia progression with the assistance of TGFβ2. In this proposal, we will investigate the role of
TGFβ2 in initiating fibrosis and activating M2 macrophages in the skeletal muscle of cancer cachectic mice.
Furthermore, we hypothesize that M2 macrophages act as a pivotal transition point driving the advancement of
severe cancer cachexia. The outcomes of this study may uncover a novel mechanism and innovative strategies
for the treatment of cancer cachexia.

Public health relevance
NARRATIVE Interest in understanding and treating cachexia has intensified due to its high mortality rate in cancer patients. Thus, interventions that can improve or preserve muscle mass and function can substantially benefit the health of cachectic individuals. The proposed studies will lead to the understanding of the immune mechanisms driving the loss of skeletal muscle mass and function.